Functional and Fitness Consequences of Human Genetic Variation

Project Summary
Along with the environment, genetic differences between cells, individuals, populations, and species drive
phenotypic differences at each level of biological organization. My research program develops computational
and statistical methods to quantify the functional and fitness effects of natural genetic variation. Using humans
as a model, specific research themes include studying the genetic basis, molecular mechanisms, and functional
and fitness consequences of 1) human aneuploidy and 2) hominin phenotypic divergence.
Aneuploidy affects more than half of human embryos and is the leading cause of pregnancy loss. My lab
seeks to understand the extent and phenotypic consequences of various forms of aneuploidy and sub-
chromosomal structural variation, scaling from the level of gene expression up to cellular and organismal
phenotypes. To this end, I have developed a statistical approach to quantify the relationship between copy
number and expression of individual genes. By applying this approach to samples with combined DNA and RNA
sequencing data, we will measure the expression consequences of copy number alteration and the possibility
that certain genes are “buffered” against its effects. We will also improve methods for detecting mosaic
aneuploidy in single-cell data, helping resolve controversy about its incidence and implications for human
embryonic development. Extending beyond embryos, we will mine single-cell genomic datasets to profile tissue-
wide landscapes of chromosomal mosaicism and cell-type-specific maps of dosage sensitivity.
A complementary approach for studying fitness-altering mutations focuses on evolutionary timescales.
Previous research has established that regulatory changes influencing gene expression play a primary role in
phenotypic divergence. Introgression of Neandertal and Denisovan sequences into modern human genomes
provides a unique opportunity to characterize such regulatory substitutions. Through a large-scale analysis of
allele-specific expression, I recently demonstrated that one quarter of persisting Neandertal sequences confer
significant cis-regulatory effects. We will extend this work to Denisovan introgression by measuring allele-specific
expression in cell lines derived from Oceanic individuals. This will allow us to contrast expression effects of
mutations that arose in different hominin groups, testing hypotheses about lineage-specific and shared patterns
of hominin regulatory evolution. In addition to gene expression levels, genetic variation influencing alternative
splicing constitutes a primary link to phenotypic variation and disease. To understand its role in hominin evolution,
we will quantify the effects of archaic alleles on patterns of alternative splicing. By contrasting expression and
splicing effects of introgressed and control mutations of non-archaic origin, we will seek general insights into the
characteristics of regulatory changes that drive phenotypic divergence.

Public health relevance
Project Narrative The work described in this proposal seeks to quantify the functional and fitness effects of genetic variation contributing to human complex traits. This includes characterizing the landscape and functional consequences of severe mutations such as aneuploidy and structural variation, which may frequently occur in mosaic form, hidden to traditional genomic assays. We also seek to understand the mechanisms shaping functional genetic variation over evolutionary timescales, using admixture among archaic (Neandertal and Denisovan) and modern humans as a model to study functional genomic divergence and its contribution to human phenotypes and diseases.